Unraveling the Hematopoietic Origins and Functional Heterogeneity of Macrophages

PROJECT SUMMARY
Macrophages are highly versatile innate immune cells that are essential for a range of functions, including
coordination of inflammatory responses, regeneration, and tissue homeostasis. Heterogeneous subsets of
macrophages arise from two primary hematopoietic waves. The primitive wave generates tissue-resident
macrophages with specialized functions, whereas the definitive wave generates hematopoietic stem/progenitor
cells (HSPCs) that differentiate into traditional circulatory macrophages. Imbalances in macrophage number or
activation can lead to significant tissue dysfunction and disease. Unfortunately, the specialized roles of distinct
macrophage subsets in immune and non-immune contexts remain poorly understood due to limitations in our
ability to isolate and track subsets long-term in vivo. To circumvent these technical challenges, I will capitalize
on the advantages of the zebrafish model, specifically their transparency throughout development, to track the
dynamics of distinct macrophage subsets from their genesis to destination tissues. This proposal will leverage
the transcription factor interferon regulatory factor 8 (Irf8) as a tool to separate macrophage populations based
on their hematopoietic origin and will identify their autonomous functions in: (i) establishing tissue macrophage
heterogeneity, (ii) mounting responses to challenge, and (iii) maintaining ratios of other blood lineages.
Irf8 is required to generate primitive macrophages, but its role in regulating definitive macrophages
remains poorly understood. Herein, I identify irf8 expression within a subset of emerging HSPCs, suggesting the
presence of distinct irf8+ and irf8- definitive macrophage subsets. As such, I posit that macrophage heterogeneity
can be classified by both irf8 expression and hematopoietic origin. I will investigate the functional and
transcriptional differences between irf8+ primitive, irf8+ definitive, and irf8- definitive macrophages. In Aim 1, I
will determine the heterogeneity of primitive and definitive macrophages across tissues from organogenesis to
adulthood, the first longitudinal analysis of tissue macrophage dynamics. To achieve this, I designed a Cre/loxP-
based lineage tracing system under the irf8 promoter to label macrophage subsets by their irf8 expression and
hematopoietic origin, i.e., primitive or HSPC-derived. Through Aim 1, I will define the dynamics of macrophage
subsets in their distribution across tissues, their differential responses to injury or systemic infection, and their
unique transcriptional profiles. In Aim 2, I will determine the specialized functions of Irf8 within primitive and
definitive macrophages as they relate to the production of macrophages versus other blood cells and colonization
in tissues. I will achieve this by rescuing irf8 specifically within irf8+ primitive or irf8+ definitive macrophages in a
global irf8 mutant background. By elucidating the ontogeny, heterogeneity, and functional contributions of distinct
macrophage subsets, this research will provide new insights into macrophage biology and uncover novel
therapeutic targets for manipulating macrophage functions in tissue repair and hematologic diseases.

Public health relevance
PROJECT NARRATIVE Aberrant macrophage activation or imbalances in macrophage numbers contribute to chronic inflammation, autoimmune disorders, and hematologic cancers. This proposal seeks to elucidate the distinct roles of macrophage subtypes and their unique regulation by the transcription factor Irf8 in the context of tissue health and disease. This proposal directly addresses a core NIH objective by gaining new insights into molecular pathways that influence clinical manifestations of hematologic disorders.